PA22-176, SBIR, Phase I, Development of a SARS-CoV-2 emerging variant infectivity and immune evasion panel to quantify the efficacy of vaccine booster induced neutralizing antibodies.

Summary
As the COVID19 pandemic and vaccine deployment continue there is an urgent need to monitor emerging
variants for their infectivity and ability to escape both prior infection and vaccine induced neutralizing antibodies.
Currently, there is no way to rapidly quantify emerging variants infectivity and immune evading capacity. The
standard for quantifying viral infectivity involves the use of harvested viral isolates and performing quantitative
plaque assays, which are tedious and time consuming. Additionally, the use of infectious SARS-CoV-2 requires
high-level containment in BSL-3 facilities that limits its application in common clinical and research laboratories.
Pseudoviruses have been widely used to model SARS-CoV-2 infectivity and antibody neutralization.
Pseudoviruses, such as those derived from lentivirus and vesicular stomatitis virus, can mimic the entry process
of SARS-CoV-2. However, these pseudovirions consist of mostly non-coronavirus structural proteins and require
2-3 days to generate results. Recently, a novel hybrid alphavirus-SARS-CoV-2 pseudovirion (HA-CoV-2) has
been developed by the P.I. (Hetrick) for rapid (3-6 hours) and accurate quantification of viral infectivity and
sensitivity to neutralizing antibodies.
The HA-CoV-2 particle is a non-replicating SARS-CoV-2 virus-like particle
(VLP) composed of only SARS-CoV-2 structural proteins (S, M, N, and E) and a RNA reporter genome derived
from a fast expressing alphavirus vector. Our preliminary studies have demonstrated that the HA-CoV-2 assay
can rapidly quantify the differences in neutralizing antibodies from vaccinated and previously infected individuals
to specific SARS-CoV-2 variants. Virongy has recently licensed the HA-CoV-2 technology from George Mason
University, and plans to develop commercial kits with panels of HA-CoV-2 particles that represent the SARS-
CoV-2 variants currently in circulation with the greatest infectivity and potential for immune escape. As viral
variants continue to emerge there is an urgent need to monitor the infectivity and evaluate the effectiveness of
the vaccines on emerging variants. The HA-CoV-2 system would provide a robust platform for rapid and accurate
quantification of viral variant infectivity and the neutralizing antibody response. We propose to develop a HA-
CoV-2 pseudovirus-based panel to examine infectivity and neutralizing antibody response with two specific aims.
Specific Aim 1 is to screen the 50 most prevalent SARS-CoV-2 variant spike proteins in circulation and identify
the emerging variants with the highest infectivity using the HA-CoV-2 pseudovirus platform. Specific aim 2 is
to conduct antibody neutralization assays of each COVID variant in circulation and determine the sensitivity of
each variant to both vaccine and infection induced anti-serum and convalescent plasma. For this study the WHO
International Standard and Reference Panel for anti-SARS-CoV-2 antibody will be screened along with a
standard recombinant RBD antibody. Following the initial screening the top 5 variants will be selected to develop
a commercial panel kit for vaccine and booster developers to evaluate the efficacy of their prophylactics. As part
of this screening process Virongy plans to collaborate with John Hopkins university and other non-profit public
health organizations to provide all the data acquired in this study. The HA-CoV-2 pseudovirus are currently
marketed on Virongy’s company website (virongy.com) for research use only.

Public health relevance
Project Narrative Virongy has recently licensed a new SARS-CoV-2 pseudovirus technology (HA-CoV-2) from George Mason University, and plans to develop a SARS-CoV-2 emerging variant infectivity and immune evasion panel for rapidly quantifying the efficacy of the latest vaccines and boosters under development. The HA-CoV-2 system would provide a robust platform for high-throughput, rapid (3-6 hours) and accurate quantification of neutralizing antibodies for infected and vaccinated people.